Evaluation of Left Bundle Branch Area Pacing As A Rescue Strategy for Cardiac Resynchronization Therapy Non-response in Patients With Heart Failure: A Randomized Controlled Trial

Overview: I am reapplying for a 5-year Career Development Award (CDA) to support my overarching goal of
studying how imaging tools can improving care of heart failure (HF) patients who require device therapy. This
will be accomplished through the completion of mentored research activities and formal training designed to
provide the skills necessary to become an independent investigator. During the course of my award, I will study
an innovative method of cardiac resynchronization therapy (CRT) in patients with HF who have not had an
improvement in cardiac function with the standard treatment of care. I also plan to establish the feasibility of
cardiac MRI to assess cardiac function over time in patients with heart failure treated with device therapy.
Significance: HF is one of the most common conditions cared for by the Veterans Health Administration and
has a 15% annual mortality rate in VA patients. Approximately 50% of the hospitalizations for HF occur in
patients with reduced ejection fraction (HFrEF). In these patients, a primary treatment goal includes strategies
to increase the cardiac fraction, which has been shown to improve symptoms and decrease the risk of sudden
cardiac death. In patients who also have a left bundle branch block, the main therapy has involved placing
cardiac pacing leads in the right ventricle and in a cardiac vein overlying the left ventricle, referred to as CRT.
However, up to 40% patients who undergo CRT fail to experience the expected improvement in cardiac
function and symptoms after 6 months and are referred to as “non-responders.” This study aims to improve
cardiac function in “non-responders” by pacing the heart from the left bundle branch area, thereby utilizing the
heart’s intrinsic electrical system to promote coordinated ventricular contractions. The intervention developed
in this CDA proposal has the potential for wide-reaching impact as it could significantly decrease the morbidity
and mortality of HFrEF patients and reduce costs and burdens placed on the VA health care system.
Career Plan: My primary area of research has focused on improving outcomes for patients with heart failure.
To successfully achieve my goals of improving care for heart failure patients that require device therapy, I need
further mentored training in implementation science including: quantitative and mixed methods training,
expertise in diagnostic imaging training and research (particularly cardiac MRI), further biostatistics training,
and cultivating multidisciplinary collaboration and networking skills. I will achieve these objectives through
formal coursework, seminars, and mentored research activities under the guidance of primary mentors Selçuk
Adabag, MD, MS (MVAHCS) and Chetan Shenoy, MBBS, MS (University of Minnesota Department of
Cardiology), and secondary mentors Bradley Bart, MD (MVAHCS) and Sue Duval (University of Minnesota
Department of Cardiology). The mentored research training through this grant will lay the groundwork for my
long-term goal of becoming a recognized leader and researcher focused on the use of cardiac imaging to
improve patient centered and clinical outcomes for patients with heart failure who require device therapy.
Research Plan: My primary research objective is to assess a novel method of CRT in patient with HFrEF and
LBBB, who have failed to respond to traditional CRT therapy. To execute this goal, I will complete the
following: 1) a prospective, randomized-controlled study assessing the effectiveness of left bundle branch area
pacing (LBBAP) vs continued CRT (the current gold standard) in improving cardiac function and patient
symptoms, 2) assess the accuracy and feasibility of cardiac MRI in measuring cardiac function in patients with
device therapy. The proposed training and research will generate preliminary data necessary for development
of a future Merit award proposal to be submitted in Year 4. I plan to propose a prospective, multicenter,
randomized controlled trial of the intervention evaluated in this study, which will launch my career as an
independent VA CSR&D investigator committed to improving Veterans’ cardiac health though improved
diagnostic and therapeutic treatment options.

Public health relevance
I am reapplying for 5 years of support for mentored training and research. The proposed training and research projects address a key gap in care quality for patients with heart failure with reduced ejection fraction (HFrEF) requiring cardiac resynchronization therapy (CRT): the treatment of non-response to CRT and uncertainty in the feasibility of measuring cardiac function in these patients with cardiac MRI (CMR). We plan to prospectively assess the use of a novel cardiac pacing method with a lead placed in the left bundle branch area (LBBAP) in Veterans with HFrEF whom have been identified as CRT non-responders, and to measure cardiac function using CMR in addition to traditional echocardiography. We expect that LBBAP will result in significant improvement in cardiac function versus continued CRT, and that CMR will be an accurate and feasible method to assess cardiac function in these patients with cardiac devices. This award supports my long-term goal of using cardiac imaging to improve care of Veterans with heart failure whom require device therapy.